Factors Associated with Response to Cardiac Resynchronization Therapy in Heart Failure Patients with Non-LBBB ECG Pattern

Factors Associated with Response to Cardiac Resynchronization Therapy in Heart Failure Patients
with Non-LBBB ECG Pattern
PI: Valentina Kutyifa, MD, PhD
University of Rochester Medical Center, Rochester, NY
Morbidity, mortality, and health care costs of the treatment of systolic heart failure (HF) are rapidly increasing.
Cardiac resynchronization therapy with a defibrillator (CRT-D) is cost-effectively reducing HF events and death
in HF patients with a wide QRS and low ejection fraction. However, response to CRT-D is not unequivocally
present in all patients, with less benefit in those without the presence of an ECG abnormality, left bundle branch
block (non-LBBB), posing a significant treatment challenge.
Because of the conflicting and limited data on response to CRT-D in this cohort, it is possible that we currently
treat a large proportion of HF patients with non-LBBB who have limited or no benefit from the device. Therefore,
better selection of patients for this expensive therapy is warranted. One of our recent studies suggested a clinical
benefit in patients with non-LBBB and marked echocardiography response, and identified predictors. However,
there is a need to prospectively validate these predictors of echocardiography response to CRT-D in non-LBBB
in this hard-to-treat patient population, and identify potential novel ECG and echocardiography predictors,
utilizing novel statistical methods of machine learning. We propose a prospective, observational, single-arm
study in a currently guideline-indicated cohort to validate and identify predictors of echocardiography response
to CRT-D, including novel ECG and echocardiography markers, and to assess subsequent clinical outcomes in
270 HF patients with an implanted CRT-D and non-LBBB ECG pattern.
The primary aim of the study is to prospectively validating our previously identified clinical predictors of
echocardiography response to CRT-D in HF patients with non-LBBB that could enable better patient selection.
Our secondary aim is to identify the incremental value of novel ECG and echocardiography variables to predict
echocardiography response to CRT-D in non-LBBB patients, including ECG variables of sum absolute QRST
integral and ventricular electrical activation delay, and echocardiography-derived variables of left ventricular
dyssynchrony and contractility. Then we will apply the developed predictive model to prospectively identify non-
LBBB patients with CRT-D at a risk of heart failure, ventricular arrhythmias, or death. Tertiary aim is to identify
novel ECG and echocardiography predictors of response in non-LBBB using machine learning analysis.
Study population will include 270 HF patients with non-LBBB (135 with mild HF and 135 with advanced HF) and
an implanted CRT-D with 6 months echocardiography follow-up analyzed by an echocardiography core lab, and
assessing clinical outcomes of heart failure, ventricular arrhythmias, or death.

Public health relevance
Factors Associated with Response to Cardiac Resynchronization Therapy in Heart Failure Patients with Non-LBBB ECG Pattern Cardiac resynchronization therapy with a defibrillator (CRT-D) in heart failure (HF) patients without left bundle branch block (non-LBBB) has been less beneficial to improve outcomes despite being a guideline indicated therapy, posing a significant treatment challenge. However, non-LBBB patients with echocardiography response to CRT-D have better outcomes, and pre-implant variables could predict response, identifying patients who benefit the most. In this study, we plan to enroll 270 HF patients with non-LBBB and guideline- indicated CRT-D implantation to validate our prior echocardiography predictor score, and to identify novel ECG and echocardiography predictors using conventional statistics and machine learning analysis. We will also assess the applicability of such a score for clinical outcomes of HF, ventricular arrhythmias, or death.